Chemical Tools for the Investigation and Manipulation of Protein Glycosylation

ABSTRACT - “Chemical Tools for the Investigation and Manipulation of Protein Glycosylation”
The broad goal of this proposal is the development of chemical tools that will enable the facile and robust
identiﬁcation and inhibition of glycosylation in speciﬁc cells, the mapping of glycosylation-mediated and cell-
type speciﬁc interactions, and monitoring and manipulation of carbohydrate biosynthetic pathways. The
addition of carbohydrates to proteins, or glycosylation, is one of the most common forms of posttranslational
modiﬁcations and is associated with various processes, including protein stability, macromolecular
interactions, and cellular signaling. Unfortunately, the currently available tools for interrogating these functions
fall short, which limits the study of glycosylation to expert labs. We plan to tackle this unmet need using
carbohydrate chemistry, photo-chemistry, and chemical biology in three speciﬁc aims. In Aim 1, we will
build on our development of glycosylation probes and inhibitors, with a focus on using chemical genetic
approaches to create tools to identify and perturb glycosylation in a cell-speciﬁc fashion. In Aim 2, we will
leverage the advantages of chemoenzymatic modiﬁcation of glycosylation to install speciﬁc photocrosslinkers
onto living cells, with a focus on identifying biological interactions that are mediated by glycans, as well as
mapping cell interactions. Finally, in Aim 3, we will create novel activity-based probes for measuring and
inhibiting critical enzymes responsible for monosaccharide biosynthesis. At the conclusion of these
independent aims, we will have generated new powerful tools that will have an immediate impact on the types
of questions scientists can ask about glycosylation in human health and disease.

Public health relevance
NARRATIVE - “Chemical Tools for the Investigation and Manipulation of Protein Glycosylation” Glycoproteins represent a large fraction human proteins that become modiﬁed by carbohydrates. The structure and levels of these carbohydrates often change in diseases, but the exact nature of these changes and how they aﬀect the underlying biology of diseased cells are extremely diﬃcult to determine with existing technologies. The goal of this project is to create new, facile tools that can be used by the broad scientiﬁc community where they can be applied to a range of biomedical investigations in the future.